Training in Basic Research on Aging and Age-Related Disease

PROJECT SUMMARY
Age is the largest single risk factor for the majority of diseases seen in clinics throughout the U.S. Demo-graphic
calculations predict that eliminating any single age-related disease would produce only a modest in-crease in
human health span (years of healthy life) or life span. However, postponing or decreasing the rate of aging
would retard the course of multiple age-related diseases and thus substantially increase health span and likely
life span. Our ability to develop rational approaches to preventing or intervening in the debilitating and costly
consequences of aging depends crucially on a thorough understanding of the causes of aging and how they
interact with the etiology of specific age-related diseases. Training young scientists to integrate research on
basic aging mechanisms with mechanisms of specific age-related diseases is a critical objective of this
application.
The long-term goal of this training program is to provide exceptional young scientists with the broad knowledge,
skills and interactions they will need to mitigate, through research, the enormous human and financial burdens
caused by aging and age-related diseases. This program will train postdoctoral fellows to become future leaders
in aging research. Each year, the program will train 10 talented postdoctoral scientists who will conduct research
for a 2-year period in one or more of 38 laboratories headed by outstanding preceptors at the Buck Institute for
Research on Aging, University of California, Berkeley and Stanford University. Trainees will participate in
research projects that include basic mechanisms of cellular stress responses, protein homeostasis, genomic and
epigenomic stability, stem cell maintenance, bio-energetics and energy metabolism and hormonal, growth factor
and nutrient signaling pathways. They will utilize a variety of model systems including yeast, round and flat
worms, fruit flies, fish, mice and human cells and tissues. And they will focus on an array of age-related diseases
including Alzheimer’s, Parkinson’s and Huntington’s diseases, stroke, cardiac and vascular dysfunction, cancer,
diabetes, osteoporosis and sarcopenia. Trainees will be instructed in state-of-the-art techniques in genomics,
epigenomics, drug screening, proteomics and metabolomics, as well as genetics, biochemistry, structural
biology, cell biology, and cell and organismal imaging. They will receive the benefits of diverse seminar series
and other scientific events and frequent net- working opportunities. They will also attend courses in specialized
scientific topics, as well as courses or discussion groups on geriatric medicine, ethics, presentation skills,
proposal and manuscript writing, and laboratory management skills. The program will fill an important national
and international need for high-quality advanced training that integrates basic aging research with research on
age-related disease.

Public health relevance
PROJECT NARRATIVE This postdoctoral training Program will prepare scientists from a range of disciplines for independent careers in research that aims to understand the mechanisms of aging and age-related disease. We will train the next generation of scientists and provide them with the broad knowledge, interdisciplinary skills and scientific interactions they will need to alleviate, through research, the enormous human and financial burdens caused by aging and age-related diseases.